Biospecimen Core

SUMMARY
The Biospecimen Core B is designed to support all aspects of this SPORE grant that need to use or analyze
biospecimens. We have 4 specific aims that are designed to span the needs of the projects and include potential
future work, including the DRPs and CDPs. Our aims include: Aim 1: To collect, store and distribute human
biospecimens with complete clinical, pathological, and demographic annotation. Aim 2: To conduct or assist in
the collection, maintenance and distribution of HNSCC cell lines. Aim 3: To conduct or assist in preparation for
genomic analyses of biospecimens. And, Aim 4: To conduct or assist in the in situ molecular pathology analyses
of biospecimens. In the body of the proposal we expand on our capacities and preliminary data for each aim.
We also illustrate how the core will meet the needs of the relevant specific aims of each project. Overall, we
look forward to being a key tissue provider and analysis facility to allow the SPORE project to seamlessly
generate data from the Yale and Fox Chase Cancer Center tissue resources.

Public health relevance
Narrative The Biospecimen Core provide unified comprehensive tissue management for the HNC SPORE. This includes tissue collection for banking and from clinical trials, as well as cell lines collection and tissue analysis including nucleic acid sequencing and immunohistochemistry, quantitative fluorescence and imaging mass cytometry